Type III effector-cofactor dynamics within the cellular environment

DESCRIPTION (provided by applicant): Pseudomonas aeruginosa is an opportunistic Gram-negative pathogen that is intrinsically resistant to antimicrobials and difficult to treat. The organism possesses a type III secretion system that is critical for evading innate immunity and establishing acute infections in compromised patients. The most toxic and destructive type III effector produced by P. aeruginosa is ExoU, whose expression is correlated with poor clinical outcomes in human infections. ExoU possesses phospholipase A2 activity, which is detectable from recombinant enzyme preparations only when a eukaryotic cofactor is provided with membrane substrates. In this new application the dynamic features of ExoU will be analyzed as a model system for understanding how the secreted T3S effectors interact with eukaryotic cofactors to affect cellular physiology. A major advance has been achieved with the discovery of ubiquitin as the main cofactor for ExoU-mediated phospholipase activity. Along with the eukaryotic cytoskeleton, the ubiquitin system is a significant target that pathogens manipulate to facilitate bacterial replication and transmission to new hosts. Ubiquitin mediated activation of ExoU represents a novel mechanism of manipulation of the host. This study is designed to functionally define the domains of ExoU involved in recognition of membrane substrates and ubiquitin. Regional and global changes in both ExoU and ubiquitin in response to cognate binding partners and liposomes will be measured utilizing state-of-the art biophysical approaches for characterizing native protein structure in solution. The completion of these aims will provide essential information towards the design of novel inhibitors and contribute biological tools to study essential eukaryotic processes and other virulence factors that are homologous to ExoU.

Public health relevance
PUBLIC HEALTH RELEVANCE: During co-evolution, pathogens have exploited the essential eukaryotic ubiquitin pathways to facilitate replication and spread to the next host. Our biochemical studies of ExoU, a type III secreted phospholipase, indicate that ubiquitin is an essential cofactor for the activation of ExoU cytotoxicity. We will use the interaction of ExoU and ubiquitin to define the activation mechanism, critical structural components controlling activation and amino acid residues important for ExoU-ubiquitin interaction. This research is poised to reveal additional mechanisms for the manipulation of the host ubiquitin system, uncover new insights into mammalian cellular biology and provide unique targets and biological tools for translational applications.